VACCINES FOR CHLAMYDIA TRACHOMATIS INFECTIONS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The objective of this project is to demonstrate that Chlamydia trachomatis proteins stimulate vigorous immune responses in immunized rhesus macaques. This is a pre-clinical study in a nonhuman primate model with direct translational relevance to studies in humans.